2022 Endothelial Cell Phenotypes GRC and GRS

Project Summary
This Gordon Research Conference (GRC), “Endothelial Cell Phenotypes in Health and Disease”, and the
accompanying Gordon Research Seminar (GRS, organized by and for trainees) of the same name have the
underlying hypothesis that a better understanding of differential endothelial cell phenotypes and functions is
distinct tissue environments is important basic knowledge, and this knowledge is crucial for proper vascular
repair and tissue regeneration. The goals are to bridge existing knowledge and communication gaps between
researchers at all levels (students, postdocs, junior and senior scientists in academia and industry) who study
endothelial cell biology and heterogeneity, and those who study vascular disease, bioimaging, and tissue
engineering and regenerative medicine. These fields have recently developed paradigms, tools and models to
aid this goal, and this integration is predicted to move all fields forward towards timely translation of basic
discoveries. This GRC will strongly foster lasting interdisciplinary interactions and collaborations amongst NIH-
funded and international vascular and stem cell biologists, between academic and industry scientists, and
develop the next cadre of scientists at the intersection of these fields by exposure to new ideas, issues and
opportunities. The associated GRS will also support these goals with an emphasis on trainee development.
The GRC Chair and vice-Chair are leaders in the field and well-suited to organize the meeting. The meeting
goals will be accomplished by bringing together a selected group of researchers (about 150 participants) to a
small, semi-isolated site (near Barcelona, Spain) for a week, in a venue and meeting structure designed to
foster extensive discussion after presentation of largely unpublished data, and to promote informal interactions
and networking through shared meals and afternoon social activities that especially benefit trainees. Invited
speakers are chosen based on excellence in research, topic, and willingness to engage trainees. Participants
will be chosen based on topic and demographics. Female and minority speakers have been invited, and those
groups will be encouraged to apply as participants. A GRS pre-meeting will be organized by trainees and for
trainees (with limited input from GRC chairs and faculty mentors that will attend the GRS), and feature
presentation of trainee work, to facilitate networking among this group and provide them with a peer group as
they transition into the larger meeting. This GRC/GRS meeting will have a strong and lasting impact on the
field, as it addresses important basic questions and health issues in vascular biology at a propitious time.

Public health relevance
Narrative The Gordon Research Conference on Endothelial Cell Phenotypes in Health and Disease will promote new knowledge integrating basic mechanisms of endothelial cell heterogeneity with regulation of tissue repair and regeneration. This is a relatively small meeting with about 150 attendees that is designed to foster networking and discussion, exchange of new unpublished data and ideas, and to jump-start collaborations that will move the field forward. An associated Gordon Research Seminar, organized by and for trainees, will encourage the next corps of interdisciplinary vascular biologists to innovate and rejuvenate the field and this two-pronged approach will allow researchers to focus on important basic science questions and tackle urgent health issues in vascular biology.